Thymosin Beta4 Promotes the Recovery of Peripheral neuropathy in Type II Diabetic

DESCRIPTION (provided by applicant): Peripheral neuropathy is one of the major complications of diabetes. There is a compelling need to develop effective therapeutic approaches specifically designed to improve neurological function in the damaged peripheral nervous system after diabetes. Thymosin β4 (Tβ4), a major intracellular G-actin- sequestering peptide, has multiple biological functions, including promotion of remodeling of injured and damaged tissues, and increasing angiogenesis after myocardial infarction. However, the role of Tβ4 in diabetic peripheral neuropathy has not been investigated. In a novel set of experiments, our data show that Tbeta4 remarkably improved sciatic nerve vascular function and peripheral nerve function in diabetic mice, indicating that Tβ4 may have a beneficial effect on the clinical treatment of diabetic peripheral neuropathy. In this application, we therefore seek to investigate the mechanisms underlying the therapeutic effects of Tβ4 on the treatment of diabetic peripheral neuropathy. We propose that Tβ4 by improving vascular function ameliorates diabetic peripheral neuropathy. Our hypotheses are: 1. Treatment with Tbeta4 improves neurological function of peripheral neuropathy in diabetic mice. 2. The Ang/Tie2 signaling pathway mediates the therapeutic effect of Tβ4 on neurovascular function in diabetic peripheral neuropathy. 3. The PI3K/Akt signaling pathway underlies the effect of Tbeta4 on Ang1/Ang2 expression. To investigate the effect of Tβ4 on neurological outcome, type II diabetic mice which develop severe peripheral neuropathy will be treated with Tβ4 at various time points after onset of diabetes. To investigate the molecular mechanisms that mediate Tbeta4-enhanced neurovascular function in diabetic mice, the effect of Tβ4 on expression of Ang/Tie2 and activation of PI3K/Akt signaling pathway will be examined. Using pharmacological inhibitors and siRNA gene knockdown techniques, we will investigate the cause-effect of the Ang/Tie2 and PI3K/Akt signaling pathways on regulating Tβ4-enhanced neurovascular function and axonal outgrowth. These studies are innovative and will provide new insight into mechanisms underlying the neurological dysfunction of diabetic peripheral neuropathy and lead to the development of a new treatment using Tβ4. Relevance Statement: Peripheral neuropathy often stemming from diabetes is a major disability affecting millions of Americans. In this proposal, employing preclinical studies in the diabetic animal, I seek to develop a novel treatment for peripheral neuropath using Tβ4. Tβ4 is currently in a phase II clinic trial for the treatment of patients with acute myocardial infarction. In this proposal, I also elucidate the molecular mechanism by which Tβ4 is therapeutically effective. This research will provide the essential pre-clinical data for translation to a phase 1 clinical trial.

Public health relevance
PUBLIC HEALTH RELEVANCE: In this application, we propose to investigate whether thymosin β4 (Tβ4)-ameliorated neurovascular dysfunction contribute to improvement of peripheral nerve recovery in experimental diabetic mice, which may provide a novel restorative therapy for diabetic peripheral neuropathy.